Occidiofungin as a new lead against the enteric AIDS-OI cryptosporidium

Project Summary
The enteric protozoan Cryptosporidium is an AIDS-OI pathogen, a water-borne parasite that caused >100
deaths in the 1993 outbreak in Milwaukee, WI. Cryptosporidium is a biodefense category B agent, presenting
a credible security threat. It is also one of the top few diarrheal agents that afflicts children in developing
countries. However, no drugs are FDA-approved to treat cryptosporidiosis in AIDS patients. Nitazoxanide is
the only drug approved for use in immune-competent individuals, whereas it is not fully effective. Therefore,
there is a need to develop new anti-cryptosporidium drugs, particularly for AIDS patients and children.
This project is developed based on recent observation that occidiofungin, a glycolipopeptide, possessed
outstanding anti-cryptosporidium activity in vitro with limited cytotoxicity (EC50 = 120−138 nM vs. TC50 =
~1.0−2.5 μM). Occidiofungin is an amphipathic molecule, consisting of a hydrophilic body and a hydrophobic
tail. It is nonabsorbable by the digestive system, and could be accumulated in the gastrointestinal tract.
Because Cryptosporidium differs from other apicomplexans by its unique “epi-cytoplasmic” lifestyle (i.e.,
intracellular, but extra-cytoplasmic on the intestinal epithelia), a non-systemic drug with mucoadhesive
property like occidiofungin has the advantage to act more effectively on the parasite.
The strong preliminary data allows the team to build a central hypothesis that the non-systemic occidiofungin
can serve as a novel structure for potentially developing new anti-cryptosporidium therapeutics. To test the
hypothesis, the team will conduct in vivo experiments to achieve the following two specific aims:
Aim 1 is to definitively verify the anti-cryptosporidium activity of occidiofungin two mouse models: an acute
infection model in IL-12 knockout mice, and a newly developed chronic infection model in R2G2 mice.
Aim 2 is to determine the gastrointestinal pharmacokinetics of occidiofungin, including its distributing kinetics
in the luminal contents, mucus layers and mucosa among various GI segments, and its correlation with anti-
cryptosporidium efficacy. Its mucoadhesive property in vitro will also be investigated.
The long-term goal of the project is to explore non-systemic drugs for potential development of therapeutics
against the enteric cryptosporidium. The completion of the two aims will ultimately determine whether
occidiofungin can be pursued further as an anti-cryptosporidium lead, and justify next stage of investigation
(e.g., lead optimization and formulation aimed to improve the mucoadhesive property, anti-parasitic efficacy,
selectivity and safety). Data obtained in this project may also provide basis for exploring the potential of
occidiofungin and its derivatives against other enteric parasites (such as Giardia and Entamoeba).

Public health relevance
Project Narrative The enteric protozoan parasite Cryptosporidium causes life-threatening opportunistic infection in AIDS patients (AIDS-OI), for which FDA-approved treatments are unavailable. In this drug discovery project, a team of experts in protozoan parasitology and antimicrobial biochemistry will explore occidiofungin, a unique glycolipopeptide, for potential development of a new therapeutics against the AIDS-OI cryptosporidiosis.